Integrating Costs Into Shared Decision-Making for Heart Failure with Reduced Ejection Fraction

PROJECT SUMMARY
Effective shared decision-making is central to patient-centered care. However, out-of-pocket costs have
been left out of most efforts to promote shared decision-making. This is despite the fact that these costs affect
critical issues such as medication adherence and patients' ability to afford other medications or non-medical
expenses. Financial toxicity is a real consideration, particularly for individuals with financial constraints.
Out of pocket costs figure prominently into many decisions in cardiovascular disease. They have recently
risen to prominence in the context of chronic heart failure with reduced ejection fraction (HFrEF). This is
principally due to the approval and subsequent guideline recommendation for the novel drug sacubutril-
valsartan. This drug improves mortality appreciably (absolute all-cause mortality reduction of 2.8% over 27
months) over standard therapy such as ACE-inhibitors and Angiotensin Receptor Blockers. However, it is
expensive, with variable but often high co-pays. In contrast, alternative drugs are very inexpensive.
Effective shared decision-making for sacubutril-valsartan requires addressing cost and engaging in
discussions about tradeoffs between cost and considerations such as mortality risk. Developing methods for
doing this effectively is particularly critical for low and fixed income patients, for whom financial toxicity or side
effects may be greatest. It is also challenging and important for African-Americans, for whom clinical evidence
is limited and for whom an additional drug is indicated that was not reported in the primary trial. Both
populations also face barriers related to health literacy and numeracy. Cost-related decision-making regarding
sacubutril-valsartan is thus most challenging for patients least-equipped to do it.
The proposed project will bring together expertise in heart failure, decision science, and ethics. It
addresses multiple barriers to cost integration. Most importantly, it addresses both communication of benefits
associated with sacubutril-valsartan and the integration of patient-specific cost into the clinical encounter. This
is important because this medication is a guideline-recommended therapy. The first two developmental aims
involve systematically studying: a) how and how often cost is addressed in patient-provider encounters
regarding sacubutril-valsartan (using commercially-available data of recorded encounters); and b) the impact of
different ways of framing information about the drug and its alternatives and the impact of different levels of
cost on patients' likely choices about whether to initiate it (using a mix of HFreF patients and. The third aim
involves conducting a stepped-wedge preliminary efficacy trial to assess the impact of integrating patient-
specific cost into clinical encounters for patients with HFrEF.
This project is innovative and designed for impact. It will directly impact the heart failure community. It will
also provide novel and valuable data that can be applied to numerous other cardiovascular conditions.

Public health relevance
PROJECT NARRATIVE The proposed project addresses a critical barrier in achieving patient-centered, shared decision-making regarding treatment of congestive heart failure: incorporation of out of pocket costs. The project focuses on the particular clinical decision about use of sacubutril-valsartan, a novel drug for heart failure that is effective and guideline-recommended but has highly variable and often significant out-of-pocket costs. Capitalizing on the strengths of an experienced multi-disciplinary team, we will: 1) observe the way that this decision is discussed and the extent to which cost is incorporated in practice; 2) assess the impact of both how the decision is framed and the amount of out of pocket cost on patient preferences regarding this drug; and 3) conduct a trial to examine the impact of providing point-of-care patient-specific cost estimates on cost-sensitive shared decision-making.